Ectodermal-neural cortex 1 and neuronal vulnerability to tau pathology in Alzheimer's disease

In many neurological diseases, specific subsets of neurons are more sensitive to dysfunction and degeneration
than others. In Alzheimer’s disease (AD), excitatory (EX) neurons are preferentially vulnerable to tau pathology
which defines the pathogenesis and progression of dysfunction in AD. Understanding the molecular origins of
selective neuronal vulnerability is of fundamental importance for all of the neurodegenerative diseases including
AD. Using single-nucleus RNA-seq dataset analysis and weighted gene co-expression network analysis of the
transcriptomic signatures of different cell types from non-AD cases, we identified novel subproteome gene
signatures in EX neurons that may serve as potential master regulators of selective neuronal and regional
vulnerability to tau pathology in early AD. The ectodermal-neural cortex 1 (ENC1) is one such potential master
regulator. Although the role of ENC1 in AD has not been thoroughly investigated, if it functions as a master
regulator as predicted by bioinformatics analysis, it may be possible to regulate ENC1 levels to control tau
pathology and thwart the onset or progression of AD. Preliminary analysis of human entorhinal cortex from AD
and control brain specimens has revealed that ENC1 is enriched in the nucleus of EX neurons in control brains,
while cytoplasmic ENC1 levels are elevated within neurons that show accumulated pathological tau species in
AD specimens. The interaction between ENC1 and tau correlates directly with levels of pathological tau.
Furthermore, forced overexpression of ENC1 mainly in the cytoplasm increases tau aggregation and seeding
activity, whereas knockdown of ENC1 reduces these pathological changes. ENC1 has been shown to increase
the neurotoxicity of mutant huntingtin under ER stress through the interaction with p62 and the inhibition of
autophagy flux. Our new data also show ENC1 overexpression increases pathological tau accumulation, p62
puncta formation and autophagy dysfunction, implicating impairment of p62-mediated autophagy as a
mechanism underlying the cytoplasmic accumulation of ENC1 and pathological tau in neurons. Based on these
preliminary data, we hypothesize that cytoplasmic ENC1 contributes to the vulnerability of EX neurons to
tau pathology, and that reducing ENC1 in EX neurons will enhance the autophagy pathway thereby
protecting these EX neurons from selective neurodegeneration in AD. To test this hypothesis, this proposal
will (1) determine the effect of ENC1 on tau aggregation and propagation in human cerebral organoids; (2)
investigate the role of ENC1 in autophagy pathway and if this pathway is involved in ENC1-induced tau
aggregation and propagation in vitro; and (3) determine if cell-type specific manipulation of ENC1 affects
neuronal autophagy, AD pathology and cognition in vivo. The proposed studies will provide mechanistic insight
into the role of ENC1 as a master regulator of tau homeostasis and will also provide greater insight for developing
novel therapeutics targeting ENC1-dependent pathways to prevent, treat or delay the neurodegeneration in AD.
Furthermore, this work will elucidate novel mechanisms underlying selective neuronal vulnerability in AD.

Public health relevance
It is largely unknown why some neurons are highly vulnerable to degeneration in early Alzheimer's disease (AD), and why others are not. We have proposed experiments to determine if, and why ectodermal-neural cortex 1 (ENC1) may be responsible for this selective neuronal vulnerability in early AD. The proposed studies will provide mechanistic insight into the role of ENC1 in mediating the degeneration of vulnerable neurons, and identify new therapeutic targets for the prevention and treatment of AD.